Technical development of cardiovascular Magnetic Resonance Imaging

This is a collaborative program between NHLBI and Medstar Washington Hospital Center in DC. The laboratory was founded in January 2021 and during spring and summer 2021 the research protocol was IRB approved, reliance agreement signed and contracts for data transfer arranged. The start of patient enrollment is September 10 2021. The MRI sequence development will primarily be conducted at NIH NIH Clinical Center in Bethesda, Maryland and the clinical testing primarily at the MRI scanner dedicated for cardiovascular use at Medstar Washington Hospital Center, DC.